Role of VTA-Amygdala Neural Circuit in Mediating Anxiety-Related Behaviors

PROJECT SUMMARY
Anxiety disorders are the most common psychiatric illness, afflicting 273 million people worldwide. The
symptoms of anxiety disorders are highly complex and the causes are poorly understood. Additionally, a
substantial number of patients suffering from anxiety disorders also present with depressive-like symptoms,
which complicates the investigation of the underlying mechanisms. In this project, we propose to take
advantage of the repeated social defeat stress (RSDS) model that induces anxiety (A) or mixed
anxiety/depression (A/D) phenotypes in separate subgroups of mice, in an effort to dissect the
neurophysiological substrate regulating anxiety behaviors. Using this model, we unexpectedly identified that
specific neural circuit pathological activity is exclusively correlated with anxiety behaviors. Briefly, while RSDS
induces severe anxiety behaviors in all subjects exposed, a subset of mice is segregated based on their
depressive phenotypes: profound anhedonia and avoidance-displaying mice (susceptible) from mice not
displaying these depressive symptoms (resilient). Thus, in this project, we label them as anxiety (A) and
anxiety/depression (A/D) subgroups. Numerous studies have implicated the role of ventral tegmental area
(VTA) dopamine (DA) subcircuits in anxiety and depression. We previously observed that maladaptive firing
activity occurred in the VTA DA neurons projecting to the medial prefrontal cortex (mPFC) and VTA DA
neurons projecting to the nucleus accumbens (NAc) in A/D mice (depression-susceptible mice), but not in A
mice (depression-resilient group). We further demonstrated the causal link between the firing maladaptations in
those circuits and depression-related behaviors. Surprisingly, with the support of our R21, using ex vivo
electrophysiological studies we show that the firing activity of VTA neurons projecting to the amygdala (VTA-
AMG) is dramatically decreased in both A/D and A mice, and this VTA-AMG circuit activity correlates with the
expression of anxiety phenotype but not depressive-related phenotypes. Based on these preliminary findings,
our central hypothesis is that the VTA-AMG circuit plays a crucial role in the anxiety-like behaviors
observed in both A/D and A mice following RSDS. To test this, we propose three Specific Aims: (I) to
investigate the pathological cellular and molecular alterations of VTA-AMG DA circuit neurons in A/D and A
male and female mice by use of in vivo optrode recordings and ex vivo brain slice recordings; (II) To define
how RSDS alters the activity of VTA-AMG DA neurons during the emergence and expression of anxiety using
in vivo calcium fiber photometry recordings, and finally (III) to determine the functional role of VTA-AMG DA
neurons in mediating RSDS-induced anxiety behaviors by optogenetically manipulating these circuits in male
and female mice. By utilizing these cell type- and circuit-specific electrophysiological, in vivo calcium imaging
and optogenetic techniques, we will determine if a causal relationship exists between the neuronal activity of
VTA-AMG DA circuit and anxiety-related behaviors.

Public health relevance
PROJECT NARRATIVE Anxiety disorders may arise from their own, independent neural causes, but a substantial number of patients with anxiety disorders often also experience symptoms similar to those who have major depressive disorder (MDD). It is known that the rodent model of repeated social defeat stress (RSDS) induces anxious-only and anxious-depressed subpopulations, which provides the unique opportunity to explore and dissect the neural mechanisms underlying anxiety-related behavioral symptoms, and to investigate potential drug targets to alleviate or abolish these neuropsychiatric conditions.